Automated Physiological Assessment of Chronic Pain in Daily Life

The United States is in the midst of dual epidemics of chronic pain and opioid abuse, with approx. 20% of the
population in persistent pain, and over 40,000 lives lost each year to opioid misuse. Chronic back pain (CBP) is
the most common pain disorder and one of the major reasons for prescribing opioids. Strategies to help reduce
CBP pain without opioids are therefore urgent. A promising opioid alternative are psychological interventions
that reduce pain intensity, interference and negative emotions, and do not just target the physical pain intensity
as many of the traditional pharmacological approaches do. However, these interventions are not often temporally
aligned with pain episodes.
We propose to establish diagnostic physiological markers of ongoing clinical pain by capturing ongoing
clinical pain and the associated physiological fluctuations and psychological processes. We will develop fully
automated real-time detection of ongoing pain in N=80 CBP patients from physiological signs collected in
everyday life. We will record multiple physiological signals (electroencephalogram (EEG), facial
electromyography (EMG), electrooculography (EOG), electrodermal activity (EDA), and heart rate (HR)) from
two wearable device, one worn around the ears (Earable) and one worn around the wrist (Empatica). The sensing
system will be integrated with an experience sampling method (ESM) smartphone app to collect ratings of pain
and psychological processes associated with pain episodes. Our goal in Aim 1 is to establish computational
physiology-based models that can predict clinical pain in real-life. To achieve this, we will apply machine-learning
techniques to physiological data preceding pain self-reports to build predictive models of ongoing pain, with the
ultimate goal for these computational models to be able to trigger psychological interventions when needed most,
which we aim to develop in our future research. Our goal in Aim 2 is to field-test these computational models in
a new group of N=20 CBP patients.
The proposed work will afford, for the first time, autonomous monitoring of clinical pain in real-life. If the
real-life pain experience of patients can be captured in physiological patterns preceding pain, then automated
tracking of physiology has considerable potential to improve the efficacy of psychological treatments, by
providing signals to trigger just-in-time interventions. Overall, the proposed project will contribute fundamental
scientific knowledge about psycho-physiological signs of real-life pain and lay the groundwork for translational
efforts to improve outcomes of pain self-management and reduce opioid use.

Public health relevance
The United States is in the midst of dual epidemics of chronic pain and opioid abuse and treatments to reduce pain without opioids are therefore crucial and urgent - psychological treatments have shown potential but also limited efficacy thus far. In this proposal, we will record multiple physiological and psychological signs of pain to develop computational models of real-life fluctuations in chronic pain levels. The findings of this proposal will translate into psychological interventions better matched to psycho-physiological signs of clinical pain and will deepen our understanding of the multidimensional nature of chronic pain.